Mechanisms for the emergence of rhythmic behaviors

Project Summary
Normal sleep and circadian rhythms play a critical role in the developing brain. Disruptions in sleep and rhythms
during human development are a common co-morbidity in neurodevelopmental disorders including ADHD and
autism. Although the molecular mechanisms encoding cellular rhythms are well understood, little is known about
how rhythmic behaviors first emerge. I hypothesize that the developmental emergence of rhythmic behaviors is
intimately tied to metabolic state. Specifically, juvenile animals have high metabolic demands necessitating
frequent feeding; as an animal matures, consolidated periods of sleep become sustainable, leading to enhanced
memory capacity. However, it is unclear how changes in metabolic state influence the emergence of behavioral
rhythms or if the neural circuitry that regulates rhythmic behavior has conserved functions across the lifespan.
This proposal exploits the Drosophila melanogaster model to investigate the mechanism through which
sleep and feeding rhythms are initiated and influenced by metabolic state. This proposal will also offer
insight into how long-term memories (LTM) are coupled to rhythmic sleep. Finally, this proposal will use a
developmental approach to examine how sleep-wake and feeding rhythms are regulated across the lifespan. I
have determined that while 2nd instar (L2) Drosophila larvae do not show differences in sleep across the day,
early 3rd instar (L3) larvae show clear diurnal differences, sleeping more at night. My preliminary data have
characterized the development of a circuit bridge between larval DN1a clock neurons and Dh44(+) output
neurons that drives the emergence of sleep rhythms. I have also determined that Drosophila larvae experience
changes in LTM capacity over development: L3 but not L2 larvae exhibit LTM of an aversive cue. In the mentored
phase of this proposal, I will determine if the DN1a-Dh44 circuit acts as a conserved regulator of sleep timing
across the lifespan (Aim 1) and I will uncover how circadian sleep-wake circuitry communicates with
learning/memory circuits to promote the development of LTM capacity (Aim 2). In the independent phase of this
proposal, I will determine how metabolic state influences circadian-sleep circuit development (Aim 3) and how
other rhythmic behaviors such as feeding develop (Aim 4). Completion of the proposed experiments will provide
insight into how developing circuits integrate metabolic cues to drive the emergence of rhythmic behavior.
Broadly, this proposal will provide rigorous training 1) in a wide range of behavioral analyses possible
in Drosophila including adult sleep, 2) feeding rhythms and circadian neurobiology, 3) larval
learning/memory principles and circuitry, and 4) cutting-edge techniques such as machine
learning/vision approaches, each of which will complement my existing knowledge/skills. Completion of
the proposed training plan will open the door for new areas of investigation in Drosophila in my own independent
position. Furthermore, the proposed career development activities and coursework will enable me to obtain a
tenure-track faculty position.

Public health relevance
Project Narrative Circadian and sleep disturbances are a common co-morbidity in neurodevelopmental disorders. The goal of this proposal is to discern the molecular mechanisms governing the developmental emergence of circadian behavior in order to provide insight into brain maturation in health and disease.